Development of a Provider-Focused Intervention to Improve Health Outcomes in Pediatric Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
This Mentored Patient-Oriented Research Career Development application (K23) will provide protected
time for Dr. Siddika Mulchan to develop a focused program of research investigating aspects of care affecting
health outcomes in youth with sickle cell disease (SCD). The aims of this 5-year career development plan are
complementary and will increase Dr. Mulchan's knowledge and skills in: 1) mixed methods research design
and analyses, 2) intervention development and refinement specifically targeting health outcomes in youth with
SCD, 3) behavioral health clinical trials, and 4) clinical trials data analysis. The career development plan
includes frequent structured meetings with mentors and consultants, coursework and workshop attendance,
fellowship participation, and dissemination of research findings at conferences and publications. Research
activities during the K23 award include writing literature reviews (e.g., manuscript on provider communication
and health outcomes in pediatric SCD) and conducting the K23 research study (e.g., manuscripts on
qualitative findings from focus group data, use of virtual patient technology to enhance provider
communication, and efficacy-testing of the proposed intervention). Findings will be disseminated in 5
manuscripts submitted to peer-reviewed journals and conferences. The K23 study is a randomized clinical trial
that will test the preliminary efficacy of a communication-enhancement intervention for health care providers
(HCPs) in an outpatient setting to improve health outcomes in pediatric SCD. Two cognitive strategies that may
improve patient-provider communication are individuation and perspective-taking (IPT). We piloted an IPT
intervention with pediatric HCPs, and it was found to be feasible and acceptable. However, we need to refine
the intervention and test its preliminary efficacy in improving patient-centered communication. Study aims are
consistent with the NIH Stage Model for Behavioral Intervention Development and include a refinement phase,
training phase, and testing phase. Specific aims are to: 1) refine IPT by examining perspectives of adolescents
(ages 12-17 years) with SCD and their caregivers (parent or legal guardian) regarding HCP communication
using mixed methods, 2) promote the uptake of communication skills with the refined IPT in a sample of HCPs
using a pretest-posttest design with virtual patients, and 3) test the preliminary efficacy of the IPT intervention
on improving patient-centered communication in a multi-center sample of pediatric SCD HCPs using a
randomized design. Dr. Mark Litt is the primary mentor on this K23 application and has nationally and
internationally recognized expertise in areas relevant to the specific aims of this application (e.g., mixed
methods design and methodology, behavioral health clinical trials, clinical trials data analysis). Drs. William
Zempsky and Adam Hirsh will serve as co-mentors and Drs. Javeed Sukhera, Paula Tanabe, and Michael
Brimacombe as other significant contributors supporting and advising the candidate in selected areas (e.g.,
intervention development, behavioral health clinical trials, SCD clinical trials, and statistical analyses).

Public health relevance
PROJECT NARRATIVE This career development plan includes training in developing and refining interventions to improve health outcomes for youth with sickle cell disease (SCD), mixed methods study design and analyses, behavioral health clinical trials, and clinical trials data analysis. This K23 project is a randomized controlled trial that will test the preliminary efficacy of a communication-enhancement intervention for health care providers (HCPs) to be used in a pediatric SCD outpatient setting. The intervention teaches HCPs two cognitive strategies - individuation and perspective-taking - to enhance patient-centered communication, which can improve patient health outcomes, such as adherence, pain management, self-efficacy, trust, and satisfaction with care, thus reducing morbidity and mortality and promoting quality of life in this underserved population.